Biochemical Mechanisms of Eukaryotic RNA Processing

PROJECT SUMMARY/ABSTRACT
The eukaryotic transcriptome is defined by both genomic sequence and pre-mRNA processing steps that define
the composition of mature mRNAs. Nearly every human mRNA must be processed by splicing to remove introns
and cleavage and polyadenylation to be released from the transcription machinery and prepared for translation.
These processes are catalyzed by large, megadalton-sized macromolecular machines [the spliceosome and
cleavage and polyadenylation factor (CPF)] that assemble on RNAs and must precisely recognize which regions
of the RNA to keep and which to discard. Failure to recognize the proper splice or 3' end cleavage sites can
destroy the protein coding potential of a message; alter the amino acid composition of the encoded protein; or
dramatically change when, where, or how much protein is produced from a given message. The Hoskins
Laboratory is focused on understanding spliceosome and CPF function in biochemical depth to illuminate how
they shape the transcriptome. To study these machines, we integrate single molecule fluorescence microscopy
with genetic, transcriptomic, and biochemical assays. In the next funding period, we will focus on how splice and
cleavage sites are recognized by the spliceosome and CPF. We will pioneer single molecule methods to follow
assembly of CPF and 3' end cleavage in real-time to answer fundamental questions about CPF function that
have proved elusive for decades. By studying how 5' splice site recognition occurs co-transcriptionally, we will
elucidate how splicing factors influence the transcriptional machinery and vice versa. We will use genetics and
transcriptomics to probe how 3' splice site recognition is coupled with proofreading to maintain the integrity of
genetic information flow. Finally, we will develop new high-throughput assays and microscopy hardware that will
provide quantitative biochemical data for splice and cleavage site recognition at the transcriptome-scale.
Together, these research directions will reveal fundamental mechanisms of the pre-mRNA processing
machineries and insights into how these machines malfunction in human diseases including cancers and
neuromuscular disorders.

Public health relevance
PROJECT NARRATIVE Human gene expression requires that RNAs transcribed from DNA genes are precisely processed by removal of intervening sequences called introns, cutting the RNA tether to the transcription machinery, and addition of a polyA tail. In many human diseases, errors in these processes can result in the incorrect protein being made or even no protein at all. In this proposal, we will study the large cellular machines responsible for pre-mRNA splicing and 3' end cleavage and polyadenylation to understand how they correctly process RNAs, how they malfunction in disease, and how malfunctions can be corrected with new therapies.